Alpha5Beta1 Integrin inhibition as a Profound Blood-Brain Barrier Stabilizing Neuroprotective Stroke Therapy

? DESCRIPTION (provided by applicant): Although stroke is the fourth leading cause of death in the U.S., the current treatment strategy of thrombolysis for the majority of strokes due to a blood clot (ischemic) has mixed results. Thus, there is an urgent need for new and better stroke therapies. We have previously demonstrated that the domain V protein fragment of the brain extracellular matrix component perlecan is both neuroprotective and neuroreparative after ischemic stroke by interaction with the brain endothelial cell receptor α5β1 integrin. Intriguingy, preliminary results now suggest that mice with an endothelial selective deletion of α5β1 integrin are profoundly resistant to experimental ischemic stroke; they show little to no signs of brain injury. Furthermore, inhibition of the α5β1 integrin with ATN-161 or its more potent isoform Ac-PhScN-NH2 conveys nearly identical resistance to stroke injury in wild type mice. This may occur via stabilization of the blood-brain barrier through increased function of the brain endothelial cell tight junction protein claudin-5, which in turn minimizes vasogenic edema, inflammation, and injury. Therefore, we hypothesize that endothelial cell α5β1 integrin could be a particularly effective therapeutic target for stroke. In this application, we propose the followig specific aims: 1. Determine the effect of endothelial cell selective α5β1 integrin deletion on experimental ischemic stroke, 2. Determine the potential of the α5β1 integrin as a therapeutic target in experimental ischemic stroke and 3. Determine, in mechanistic detail, the role of α5β1 integrin in modulating blood-brain barrier integrity and subsequent resistance to ischemic stroke. We will use several novel genetically modified mice (α5 integrin endothelial cell specific knockdown mice, claudin5 eGFP tagged mice) and newly characterized α5β1 integrin inhibitors in experimental stroke models and in vitro endothelial cell barrier assays. We expect to demonstrate that suppression or inhibition of α5β1 integrin in endothelial cells affords significnt blood-brain barrier-mediated resistance to experimental ischemic stroke, supporting our long-term goal of developing α5β1 integrin as a novel human stroke therapeutic target.

Public health relevance
PUBLIC HEALTH RELEVANCE: Although stroke is the fourth leading cause of death in the U.S., current treatment options are limited in their application and efficacy. Towards that end, we have identified a novel component of the brain's injury response derived from the brain's extracellular matrix which appears to protect cells from injury and help the brain to repair itself We further showed that this component, termed perlecan domain V, exerted its beneficial effects through interaction with the α5β1 integrin receptor on brain vascular (endothelial) cells Preliminary results now suggest that inhibition of this receptor profoundly protects the brain from stroke injury, and may do so by preventing breakdown of the blood-brain barrier. Therefore, we propose to determine the therapeutic efficacy and mechanism(s) of action of targeting the α5β1 integrin in experimental ischemic stroke with the long term goal of developing better stroke therapies.